Project 1: Role of DYNLL1 in the 53BP1 Axis of HDR Regulation

ABSTRACT
Double stranded DNA break (DSB)s are repaired by two major mechanistically distinct pathways, DNA
homology-directed repair (HDR) and non-homologous end joining (NHEJ). A decisive factor in the choice
between HDR and NHEJ is in the competition between DNA end protection (necessary for NHEJ) and DNA end
resection (necessary for HDR). DSB end resection is appropriately restricted to S/G2 phases of the cell cycle,
as HDR requires the presence of an intact sister chromatid. Depletion of NHEJ promoting factors such as 53BP1
allows DNA end resection in the G1 phase, thereby impairing DSB repair and causing genomic instability.
Conversely, loss of the HDR protein BRCA1 (critical for initiating end resection) allows the error-prone NHEJ
pathway to dominate throughout the cell cycle potentially leading to tumorigenesis. BRCA1 deficient tumors are
exquisitely sensitive to inhibitors of the DNA repair protein, poly (ADP-ribose) polymerase (PARP). Surprisingly,
loss of 53BP1 or associated factors (Shieldin complex, CST complex, etc) in these tumors render them
insensitive to PARP inhibitors (PARPi), as DNA end resection and the subsequent steps of the HDR pathway
are restored. Loss of DYNLL1, a factor that is constitutively bound to 53BP1, also results in enhanced end
resection and HDR. DYNLL1 directly binds to and inhibits MRE11, thereby blocking the initiation of DNA end
resection. Phosphorylation of DYNLL1 on serine 88 enhances the formation of DYNLL1/MRE11 complex, albeit
reducing DYNLL1’s interaction with 53BP1. Our preliminary studies suggest that DNA-PKcs is responsible for
the phosphorylation of DYNLL1 and may be critical for inhibiting MRE11 and blocking HDR in BRCA1-deficient
cells. BRCA1 impedes activation of DNA-PKcs, indirectly preventing DYNLL1 phosphorylation and the inhibition
of MRE11. In BRCA1 proficient cells DYNLL1 promotes BRCA1/BARD1 mediated ubiquitination of MRE11,
thereby facilitating end resection at DSBs. In AIM1 we propose to investigate the dynamics between BRCA1 and
DNA-PKcs and how it regulates the DYNLL1 and MRE11 activity during the cell cycle. Like DYNLL1, the Shieldin
(SHLD1–SHLD2–SHLD3) and CST (CTC, STN1, and TEN1) complexes are recruited to DSBs in a 53BP1-
dependent manner, and loss of any of the subunits is also associated with increased end resection and HDR.
Intriguingly, SHLD1 is recruited to short-resected ssDNA in G1 phase of the cell cycle. This brings up one key
issue which is how the Shieldin complex, which primarily functions in G1, influences PARPi sensitivity in BRCA1-
mutant tumors. PARPi sensitivity has now been closely tied to replication fork stability and ssDNA gap formation.
Loss of REV7 and the CST complex have been shown to de-stabilize the fork which should cause PARPi
sensitivity. This is in contrast to PARPi resistance in BRCA1-mutant cells. Together they suggest that the Shieldin
complex may have differential function in absence of BRCA1. We speculate that in BRCA1-mutant cells,
components of the Shieldin complex cannot be removed from DNA lesions thereby disrupting replication fork
dynamics and causing PARPi sensitivity. Therefore, in AIM2 we will test the hypothesis that (i) BRCA1 regulates
Shieldin localization and function at DSBs, and (ii) Shieldin is recruited to specific DNA “scars” where loss of
Shieldin confers PARPi resistance. Investigating the dynamics of these end resecting factors and their regulation
in DSB repair bear significant clinical relevance in combating PARPi resistance in BRCA1-mutant tumors.
Therefore, in AIM3, we determine how alterations in 53BP1-dependent mechanisms of attenuated DNA end
resection may drive development of PARPi resistance in the high grade serous ovarian cancer using patient
derived xenografts and primary tumors.

Public health relevance
PROJECT NARRATIVE DNA end resection has a key role in DSB repair and DNA replication. Any aberrations in DNA end resection can lead to genomic instability and also impact the therapeutic response to DNA damaging drugs. Our discovery of DYNLL1, which interacts with MRE11 to inhibit end resection, provides a functional link between two distinct end resecting mechanisms, with one directly controlling MRE11 activity and the other indirectly regulating Shieldin dependent end resection. Here we will continue to shed light on how functional interplay of the DNA end resection machinery and its regulatory circuitry impacts upon genome stability and sensitivity to PARPi.